Statistical Modeling of Alzheimer's Disease Progression Integrating Brain Imaging and -Omics Data

Understanding of the etiology of Alzheimer's Disease (AD) is complicated due to the existence of
dysregulations at different biological scales, ranging from genetic mutations to structural and functional brain
alterations. Most models for studying AD are primarily focused on unimodal analysis, but there is a lack of
systematic approaches that can integrate data across multiple scales to study the longitudinal disease
progression. For example, the molecular mechanisms of brain atrophy related to progression to AD is not well
understood. Although the promise of integrative analysis across multiple scales is increasingly recognized,
there has been limited progress in developing interpretable and systematic approaches due the fact that the
neuroimaging and -omics features have unique patterns of dependence and it is not immediately clear how to
combine these two modalities for modeling progression to AD. Another limitation is that most of the existing
methods have focused on delineating biological causes for differences between disease specific phenotypes
that does not account for heterogeneity and does not treat the disorder as a continuum, which is recommended
as per current NIA guidelines. To address these critical challenges, we develop a suite of statistical methods
for modeling disease progression in AD involving longitudinal neuroimaging (MRI) scans and cognitive scores,
combined with baseline -omics features and demographic and clinical data. Our integrative longitudinal
analysis addresses critical gaps in literature and generates more robust results that are generalizable to more
inclusive populations and yields more power in detecting true signals. We use spatially distributed voxel-wise
brain surface features derived from MRI scans that provides high resolution interpretations about the changes
in brain shape associated with disease progression. We develop predictive models which treats AD as a
continuum while integrating data across disease stages and multiple visits in a systematic manner that is able
to account for heterogeneity between and within disease stages and provides interpretable insights into
longitudinal neuroimaging and baseline -omics features that drive cognition. Our methods can be used for
developing individualized prediction trajectories for disease progression, identify latent states that are
prognostic for specific disease stages, and predict cognition at future visits that can be directly used for early
detection of high-risk individuals. We will develop and train our models using longitudinal ADNI data involving
several thousand individuals and validate our findings on an independent longitudinal B-SHARP dataset. The
statistical tools and algorithms developed will be made widely available to the broader research community. To
our knowledge, our project is one of the first to develop an integrative and interpretable statistical framework
for studying the trajectory of disease progression in AD using longitudinal and heterogeneous biomarker data
from multiple scales, which provides valuable computational tools for early detection in AD that is of
tremendous clinical importance in delivering patent centric outcomes in precision medicine.

Public health relevance
This research seeks to develop innovative statistical methods for, and address several gaps in, the longitudinal analysis of heterogeneous and high-dimensional neuroimaging and -omics data, combined with clinical and demographic features, towards the ultimate goal of advancing precision medicine for Alzheimer's Disease (AD). The primary goal is to build predictive models for disease progression in AD that incorporates unknown interactions between imaging and -omics features as well as supplementary information such as gene pathways, while accounting for heterogeneity resulting from observed as well as latent confounders. To our knowledge, our project is one of the first to develop a sophisticated integrative statistical framework for studying the trajectory of disease progression in AD using longitudinal cognitive and brain imaging data and baseline clinical, and -omics data, which provides valuable computational tools for early detection in AD that is of tremendous clinical importance in delivering patent centric outcomes.